BIOTEAM - Scientific Computing Integration Adoption Assessment and Communications Strategy

Gather information, document use-cases and NIH capabilities on platform interoperability / data ecosystems across NIH. Landscape analysis of all NIH supported controlled access data repositories. Coordination support for the Generalist Repository Initiative. Establish seamless discovery and access of data resulting from NIH-supported research across generalist repositories